Rapid, Motion-Robust, and Low-Gadolinium MRI for Pediatric Brain Tumors

PROJECT ABSTRACT
MRI is the gold standard for diagnosis, staging, and assessment of treatment response in pediatric brain tumors.
Neuro-oncology MRI protocols often take more than 20 minutes, and this prolonged duration makes it difficult
for pediatric subjects to keep motionless. Sedation is used to ensure immobility but has profound implications.
For the patients, sedation carries risks of acute anesthetic complications and the potential for adverse
neurocognitive effects in the long term. For the healthcare system, sedation increases the wait time for exams
and triples the cost.
Recent studies have raised concerns about the deposition of Gadolinium-based contrast agents (GBCAs) in
the brain and body, regardless of renal function. Due to the long life span of children and the high burden of
GBCA exposure in oncology patients, children with cancer constitute a particularly vulnerable population and
are at risk for developing long-term adverse effects that might not become manifest in other populations.
Quantitative MRI (qMRI) is a technique that can measure biophysical tissue parameters, such as T1 and T2,
reproducibly across different MRI systems and provide standard contrast-weighting images synthesized from
the measured parameter maps. However, the speed limitations of qMRI, the sensitivity to motion degradation,
and partial volume effects have hindered its clinical adoption.
This project aims to address unmet needs in pediatric tumor imaging by developing a rapid and motion-
robust qMRI acquisition. This proposal aims (i) to develop cutting-edge technologies for rapid, motion-robust,
and quantitative scans that reduce the need and the amount of sedation or rescan, thus mitigating the long-term
cognitive effects of sedatives in children, (ii) to synthesize clinically desired full-dose post-contrast images from
the measured biophysical tissue parameters acquired from a low-dose qMRI acquisition.
The developed technology will be clinically translated and deployed in children with brain tumors. The
developed techniques will be rigorously analyzed by (i) assessing the improvements in image quality of the
motion-corrected sequences on non-sedated children and (ii) evaluating the diagnostic/clinical equivalency of
the synthetic and post-contrast images on children with brain tumors. All developed technology will be
disseminated by employing the customer-to-producer (C2P) software package and the framework for image
reconstruction environments (FIRE) package, provided by Siemens Healthineers, for running the developed
techniques on clinical scanners and helping effectively disseminate to other institutes.

Public health relevance
PROJECT NARRATIVE Pediatric brain MRI is essential to accurately diagnose, monitor, and treat pediatric brain tumors. However, the current practice carries risks, including a long-term detrimental risk to a child's cognitive development posed by repeated sedation and neurotoxic properties from gadolinium-based contrast agent (GBCA) injections. This proposal aims to develop a versatile motion-robust quantitative magnetic resonance imaging (qMRI) protocol, eliminate redundancies in MRI exams, generate full-dose post-contrast images from low-dose qMRI acquisition, evaluate the diagnostic equivalency and image quality of standardized contrast-weighted images generated from biophysical tissue parameter maps, and clinically deploy the developed technology for pediatric patients with brain tumors. The new qMRI protocol will reduce the scan time, mitigate the sensitivity to motion degradation, and allow us to establish the feasibility of mitigating long-term cognitive effects and gadolinium deposition in the brain and body by reducing the need for sedation and the amount of GBCAs, respectively.